X-RAY AND NEUTRON SCHOOL 2010

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. These are experiments for X-ray and Neutron school 2010, organized by ANL and ORNL. Beamlines will prepare and organize experiments for the students themselves.